Regulation of OATP1B1 and OATP1B3 by lysine acetylation and lysine deacetylase inhibitors

Organic anion transporting polypeptides (OATP)1B1 and OATP1B3 (abbreviated as OATP1B1/3) are liver-
specific drug transport proteins that mediate uptake, from blood into the liver, of a diverse array of endogenous
compounds, environmental toxins, and many clinically important drugs (e.g., lipid-lowering statins and anticancer
agents). OATP1B1/3 are important determinants of transport-mediated drug-drug interactions (DDIs) resulting
in severe side effects, such as statin-induced rhabdomyolysis, a sometimes-fatal muscle toxicity. Dysfunction of
OATP1B1/3 significantly contributes to altered drug disposition and adverse drug events. Our long-term goal is
to delineate the molecular mechanisms underlying drug/toxin disposition through OATP1B1/3, and to predict and
mitigate OATP-mediated drug-drug and drug-disease interactions. Although it is evident that factors (drugs,
aging, disease) modulating OATP1B1/3 function could cause drug-drug or drug-disease interactions with
OATP1B1/3 substrates, unfortunately, our ability to predict such interactions is hampered due the dearth of
information on OATP1B1/3 regulation. In particular, modulating lysine acetylation, a major post-translational
modification known to alter function of numerous target proteins, including histone for epigenetic regulation, has
not been investigated for OATP1B1/3. The overall objective of this application is to determine the molecular
mechanisms governing the regulation of OATP1B1/3 by lysine acetylation, and to evaluate the impact of lysine
deacetylase (KDAC) inhibitors (KDACIs) on OATP1B1/3 expression and function. Our central hypothesis is that
OATP1B1/3 are lysine-acetylated proteins, deacetylation of which involves KDAC6; OATP1B1/3 can be
regulated at the epigenetic level by KDACIs targeting histone deacetylation and at the post-translational level by
KDAC6 inhibition. Our novel preliminary data show that 1) OATP1B1/3 are lysine-acetylated; 2) mutagenesis
mimicking hyper-acetylation of OATP1B1 and specific KDAC 6 inhibition significantly reduces OATP1B1/3
transport function; and 3) FDA-approved pan KDAC inhibitors (KDACIs) inhibiting histone deacetylation induce
mRNA and protein levels of OATP1B1/3. Guided by preliminary results, two specific Aims are outlined. In Aim
1, we will elucidate the role of KDAC6 in regulation of OATP1B1/3 lysine acetylation and transporter function. In
Aim 2, we will dissect the regulation of OATP1B1/3 by pan KDACI drugs and the interplay between epigenetic
and posttranslational regulation of OATP1B1/3 via K-Ac. A combination of proteomics, biochemical, and genetic
engineering approaches will be utilized in cell lines and in the physiologically relevant sandwich-cultured primary
human hepatocytes. The outcomes of these experiments will elucidate novel posttranslational and epigenetic
mechanism(s) involved in regulating OATP1B1/3. The knowledge gained from these studies will be invaluable
toward the rational design of novel drugs and inhibitors to optimize drug therapy while avoiding unwanted drug
interactions. This work will enhance our ability to predict altered OATP1B1/3 function by lysine-deacetylase
modulators (e.g., drugs/candidates that are HDAC inhibitors/activators and liver disease states).

Public health relevance
PROJECT NARRATIVE Organic anion transporting polypeptides OATP1B1 and OATP1B3 mediate the uptake of many drugs and endogenous compounds from blood into the liver. The proposed research will elucidate novel regulatory mechanisms that modulate the function of these important liver- specific transport proteins. Such information is essential to predict clinically relevant drug-drug and drug-disease interactions.